Validation of a human in vitro system of hepatic steatohepatitis

Phase II SBIR: Validation of a human in vitro system of hepatic steatohepatitis. ABSTRACT Non-alcoholic steatohepatitis (NASH) is part of the progressive disease spectrum of non-alcoholic fatty liver disease (NAFLD), a public health crisis affecting 75% of type 2 diabetics and 95% of obese individuals. Glucose- and insulin-regulated de novo lipogenesis in the liver, a critical step in the disease process, is severely compromised in cellular hepatocyte systems typically used for drug discovery and development, due to dedifferentiation in vitro and the requirement for supra-physiological high levels of insulin (~10,000X in vivo) and glucose (~3X in vivo) to sustain viability. The consequent lack of insulin sensitivity and responsiveness challenges the relevance of disease and target biology, limiting the confidence in target discoveries made using these systems. This, along with the use of mouse models that do not mimic human disease pathogenesis, may explain the current landscape of over 40 drugs for NASH in preclinical/clinical development without any consensus on the optimal human targets. This lack of human relevance drives high failure rates for this indication. HemoShear Therapeutics is a biotechnology company that utilizes a patented technology to recreate human liver disease biology using human primary cells. In our Phase I SBIR we developed a steatohepatitis system using hepatocytes cultured in more physiological levels of glucose and insulin. Since our last submission, we have further matured the liver-system to include human stellate cells and macrophages in addition to hepatocytes. The resulting disease model exhibits progressive steatohepatitic changes in response to a pathological milieu based on human disease risk factors and demonstrates the ability of the HemoShear liver system to assess the therapeutic efficacy and mechanisms of promising new drug candidates at clinically relevant concentrations. The purpose of the Phase II SBIR is to validate the disease relevance of the HemoShear multi-cellular model by benchmarking against clinical liver tissue samples from NASH patients, and to evaluate the effect of a diverse set of pharmacological pathway inhibitors on each of the 4 core biological pathways impacted by the NASH phenotype.!

Public health relevance
Phase II SBIR: Validation of a human in vitro system of hepatic steatohepatitis. NARRATIVE Non-alcoholic steatohepatitis (NASH) is part of the progressive disease spectrum of non-alcoholic fatty liver disease (NAFLD), a public health crisis affecting 75% of type 2 diabetics and 95% of obese individuals. In vitro cell culture and in vivo mouse models of NAFLD/NASH do not recapitulate the human disease and may explain the current landscape of over 40 drugs for NASH in preclinical/clinical development without any consensus on the optimal human targets. This lack of human relevance drives high failure rates for this indication. HemoShear Therapeutics is a biotechnology company that utilizes a patented technology to recreate human liver disease biology using human primary cells. Our Phase I SBIR and subsequent studies developed a multi-cellular steatohepatitis system that exhibits progressive steatohepatitic changes in response to a pathological milieu that demonstrates the ability to assess the therapeutic efficacy and mechanisms of promising new drug candidates. The purpose of the Phase II SBIR is to validate the disease relevance of the HemoShear multi-cellular model by benchmarking against clinical liver tissue samples from NASH patients, and to evaluate the effect of a diverse set of pharmacological pathway inhibitors on each of the 4 core biological pathways impacted by the NASH phenotype.